Role of S-nitrosylation in regulating cardiac function and disease

Modifications of protein cysteine residues have been shown to play important roles in ischemic preconditioning (IPC)-induced acute cardioprotection. We previously found C202 of cyclophilin D to be S-nitrosylated in cardioprotected hearts. C202 is highly conserved among species and can undergo redox-sensitive, post-translational modifications.

Cyclophilin D has been shown to reduce the activity of the F1-F0ATPase. We have done studies to investigate whether mutation of C202 to a serine alters the activity of F1-F0ATPase or the assembly of synthasomes. Preliminary data suggest that compared to WT-CypD, C202S-CypD exhibited increased F1-F0ATPase activity, suggesting that inhibition of ATPase activity is likely mediated through cysteine 202.

During cardiac ischemia-reperfusion, excess reactive oxygen species can damage mitochondrial, cellular and organ function. We were involved in a collaborative study which showed that cysteine oxidation of the mitochondrial protein Opa1 contributes to mitochondrial damage and cell death caused by oxidative stress. Oxy-proteomics of ischemic-reperfused hearts reveal oxidation of the C-terminal C786 of Opa1 and treatment of mouse perfused hearts, adult cardiomyocytes, and fibroblasts with H2O2 leads to the formation of a reduction-sensitive 180 KDa Opa1 complex, distinct from the 270 KDa one antagonizing cristae remodeling. This Opa1 oxidation process is curtailed by mutation of C786 and of the other 3 Cys residues of its C-terminal domain (Opa1TetraCys). When reintroduced in Opa1-/- cells, Opa1TetraCys is not efficiently processed into short Opa1TetraCys and hence fails to fuse mitochondria. Unexpectedly, Opa1TetraCys restores mitochondrial ultrastructure in Opa1-/- cells and protects them from H2O2-induced mitochondrial depolarization, cristae remodeling, cytochrome c release and cell death. Thus, preventing the Opa1 oxidation occurring during heart ischemia reperfusion reduces mitochondrial damage and cell death induced by oxidative stress independently of mitochondrial fusion.